Multi-detector Array CD-MS for Rapid Analysis of Very High Mass Analytes

Project Summary/Abstract
This proposal describes key steps towards designing a high-throughput charge detection mass spectrometer
that is optimized for very high mass particles in the megadalton and gigadalton mass range. Charge detection
mass spectrometry (CD-MS) is an emerging technology capable of accurately measuring the mass of large and
heterogeneous analytes, making it highly suitable for a wide array of applications including biopharmaceuticals
including gene therapy vectors, virus particles such as adenovirus and lentivirus, liposomes, and large
miomarkers such as lipoproteins and exosomes. CD-MS often employs an electrostatic ion trap containing a
conductive detection cylinder connected to a charge sensitive amplifier. Trapped ions repeatedly pass through
the detection cylinder, generating a square wave signal, and are individually analyzed by Fast Fourier Transform
for their mass-to-charge ratio (m/z) and charge by measuring their oscillation frequency and signal magnitude,
respectively. While a trap offers the highest charge resolution, and therefore the highest mass resolution, it
suffers from low sensitivity and can be time-consuming. For example, routine mass spectrum acquisition takes
around 15 minutes for a sample with 1012 particles/mL and the lower detection limit is approximately 1010
particles/mL. Lower concentrations also require longer to analyze. In this proposal we aim to design a detector
array CD-MS instrument capable of enhancing the sensitivity and throughput by two orders of magnitude for
heterogeneous samples where higher mass resolution is not necessary for accurately characterizing the mass
distribution. This array will consist of ten individual detection cylinders in a linear arrangement. Ions will be flown
through the array and refocused towards the central axis by electrostatic lenses. Charge sensitive amplifiers and
analog to digital converters will generate and send signals from each detector to a central processing unit such
as a field-programmable gate array (FPGA) for the signals to be packaged into files and then sent to a server for
data processing. In this investigation, development will begin by performing ion trajectory simulations for
optimizing geometric parameters of the array and focusing voltages applied to the lenses to maximize ion
transmission through the array, thereby maximizing sensitivity. These trajectories will then be used to generate
representative simulated signals. Following from that, code will be written to extract the ion m/z and charge from
the simulated signals. Alongside code development, we will explore different amplifier configurations that give
rise to the fastest analysis and best charge determination. Finally, we wish to develop an integrated circuit for
CD-MS amplifiers which has the potential to significantly improve the charge measurement precision and will
have a more robust and reproducible construction than the current custom amplifier design. The development of
this high-throughput CD-MS array is key to meeting the need for an instrument capable of accurately and rapidly
characterizing the mass distribution of very heavy biological analytes.

Public health relevance
Project Narrative Charge detection mass spectrometry (CD-MS) is a technique for accurate molecular weight determination of large species such as virus particles, gene therapy vectors, liposomes, and nanoparticles which can not be analyzed using conventional mass spectrometry. This proposal outlines a strategy for designing an array of CD-MS detectors optimized for high-throughput analysis of particles in the megadalton to gigadalton mass range with throughput and sensitivity that are both expected to be approximately 100-fold higher than ion-trap CD-MS. This instrument will be widely applicable in biopharmaceutical development, diagnostics exploration, and therapeutic target evaluation.